Sjögren’s Team for Accelerating Medicines Partnership (STAMP)

ABSTRACT
Sjögren’s Disease (SjD, formerly known as Sjögren’s syndrome) is a common systemic autoimmune
rheumatic disorder second only to rheumatoid arthritis in prevalence. It primarily affects salivary and lacrimal
glands through lymphocytic infiltration and autoantibody-mediated inflammation, resulting in significant
morbidity. Approximately one third of SjD patients have extraglandular involvement and have a remarkably
elevated risk for lymphoma. Unfortunately, limited progress has been made in addressing the many unmet
needs in SjD. Confirmatory diagnosis is multidisciplinary in nature and often results in significant delay. Scant
therapeutic options exist outside of symptom management, and results from recent clinical trials have been
disappointing. Thus, a better understanding of the pathogenetic mechanisms of disease is critical, and can
be achieved using a de- and re-construction approach. Central to this goal, is the need for deeply
characterized patients with SjD. The multidisciplinary Sjögren’s Team for Accelerating Medicines Partnership
(STAMP) is ideally poised to assemble this resource. The team’s expertise includes autoimmunity-focused
molecular biology, genetic, and epidemiologic/clinical research, and a remarkable track-record in establishing
large cohorts of participants with stored biospecimens and exquisitely detailed phenotypic characterization.
In addition to recruiting new participants, the existing cohorts will provide the unique opportunity to perform
10 to 15-year follow-up of previously evaluated SjD participants. Our proposed Disease Team (DT) is
strategically positioned to apply cutting-edge technologies to interrogate the tissue and systems
biology of SjD to identify therapeutic pathways and targets, with the following aims: 1) Planning Phase:
Develop a 5-year scientific research agenda and SOPs for phenotyping SjD patients in collaboration
with other AMP DTs and Technology and Analytics Cores (TACs). Design standardized protocols to
recruit, enroll, collect biospecimens and perform deep phenotyping of observational cohorts of SjD and
controls. Identify research priorities for SjD to better understand the molecular and phenotypic heterogeneity
and natural history at both tissue and cell levels; 2) Pilot Phase: Calibrate clinical assessments and
sample procurement across recruitment sites and evaluate SOPs. We will work closely with other DTs
and TACs to a) finalize SOPs and implement them at all sites; b) leverage our multidisciplinary expertise to
initiate the deconstruction-reconstruction of SjD via preliminary analyses of molecular and clinical data; 3)
Scale up Phase: Increase participant recruitment and work with TAC to molecularly deconstruct and
reconstruct SjD. Standardized protocols implemented across sites will enable STAMP to interrogate the
tissue and systems biology of SjD using deep sequencing and other cutting-edge technologies, to better
understand 1) the pathogenesis of SjD and identify therapeutic targets, and new biomarkers; and 2) disease
mechanisms inherent to progression of SjD from non-SjD to SjD, and from “early SjD” to “advanced SjD”.

Public health relevance
PROJECT NARRATIVE The proposed “Sjögren’s Team for Accelerating Medicines Partnership (STAMP)” is strategically positioned to apply cutting-edge technologies to interrogate the tissue and systems biology of Sjögren’s disease (SjD) to better understand 1) the pathogenesis of SjD and identify therapeutic targets, and new biomarkers; and 2) disease mechanisms inherent to progression of SjD from non-SjD to SjD, and from “early SjD” to “advanced SjD”. To achieve these goals, we plan to develop a 5-year scientific research agenda, and design standardized clinical research protocols to recruit, enroll, phenotype, and collect relevant biospecimens from, observational cohorts of individuals with SjD and controls.